Development of a continuous microbial fermentation system using reduced genome E. coli that undergo programmed autolysis and generate nuclease post-production for the manufacture of biopharmaceuticals

Continuous bioprocessing that brings with it the advantages of lower ultimate cost, a smaller
equipment footprint and energy efficiency, is beginning to be embraced by the
biopharmaceutical industry. Long term continuous fermentation requires a high level of genetic
and metabolic stability. Scarab Genomics proprietary reduced genome E. coli strains provide
the requisite genetic and metabolic stability for such long term continuous fermentations. Scarab
Genomics proposes to develop the first fully continuous platform for the production and
purification of recombinant proteins and plasmid DNA (pDNA) by replacing homogenization of
bacteria with a custom autolysis system controlled by a temperature sensitive promoter.
Distinctive features of Scarab’s Clean Genome bacteria such as the absence of all cryptic
prophage make it uniquely suited for tightly regulated lysis. Having attained proof-of-concept in
small scale culture, this application proposes to optimize this lysis system in high density (>200
OD600) continuous fermentation (C-Flow). To further facilitate the development of a continuous
system, the lysis operon will also drive the exonuclease bensonase so that as lysis occurs, the
large amount of nucleic acid that hinders downstream processing will be removed. To enable a
lysis system for plasmid DNA (pDNA) purification, bensonase in the lysis operon will be
replaced by the lambda exonuclease which digests genomic DNA but not pDNA thereby
providing an alternate system for the production of pDNA. Once optimized, this lysis and nucleic
acid digestion system will be used to express two commercially relevant test proteins. The first
will be insulin because Scarab sees the possibility of C-Flow as a vehicle for the production of
less expensive insulin and insulin related compounds to meet the objectives of the US
government and the WHO. The second will be a single chain antibody (scFv) given the
numerous applications in diagnostics and therapeutics for single chain antibodies and antibody
fragments. To prepare C-Flow for market, the application also proposes to develop upgrades to
the current system including oxygen infusion of medium using microbubble delivery and a
microbubble separation chamber for the removal of cell debris. These innovations will result in
the first continuous fermentation platform in E. coli for the production of biopharmaceuticals.

Public health relevance
Continuous bioprocessing that brings with it the advantages of lower cost and energy efficiency is beginning to be embraced by the biopharmaceutical industry and there is a need to develop continuous methods for products made in the production workhorse, E. coli bacteria. Scarab Genomics has developed a continuous E.coli fermentation system and will expand the versatility of this system by generating bacteria that will lyse after their payload of biotherapeutic product is reached. This will dramatically reduce the time and effort required to prepare fermentation material for the extraction of target biomolecules and drugs made in E. coli.